Core A: Administration

ABSTRACT
Core A (Curiel, Dong) Administration
The objective of the Administration Core is to provide overall administrative and scientific support for the Program
Project. The Core is responsible for administration and organization, fiscal management, research integration,
communication, research management, and research coordination and is vital to all activities of the Program
Project. The Administration Core interacts directly with each Project and Core in support of this goal. The
administrative functions of this Program Project involve the coordination and integration of the entire proposal.
Dr. Clara Curiel serves as the contact Principal Investigator for this Program and the Leader of the Administration
Core and provides scientific oversight to all Project and Cores. The Administration Core maintains fiscal, as well
as scientific responsibility and provides general day-to-day core support for the Program. The Administration
Core works closely with the University of Arizona Cancer Center Business Office to ensure that timely budget
updates are provided to all investigators. The Core initiates subcontracts with other institutions and reviews
invoices and documentation prior to payment to the subcontractors. The Core approves and allocates funds to
support consultants, travel, and publication costs for the Program. The Core works with the investigators, the
UACC Business Office, and the University of Arizona Sponsored Projects staff to ensure appropriate expenditure
of grant funds. Additionally, the Core coordinates communication within the Program by scheduling twice-
monthly meetings of all investigators and staff to facilitate communication and research collaboration. Additional
meetings coordinated by the Core include meetings with outside consultants and the external Scientific Advisory
Board. These meetings are essential for ensuring consistent communication and collaboration. Administration
Core staff are responsible for reporting activity to the University of Arizona IRB and to the NIH. They also serve
as an administrative and research resource to the Project and Core investigators and staff.